California Precision Medicine Research Program Consortium

The All of UsSM Research Program is an ambitious and innovative initiative that requires flexibility in the way
participants are approached, enrolled and engaged. A one-size-fits-all may not work for an initiative that strives
to recruit a large representative sample of the U.S. population, as participant cultural and other differences may
require adaptation to support inclusivity. Authorized individuals from any institution will be able to access this
valuable resource, and the value proposition for participating institutions relies on a shared vision of how All of
Us will advance research and improve health. We assembled a multidisciplinary team of Regional Medical
Centers (RMCs) in a large consortium of organizations in California. The All of Us California Precision
Medicine Consortium (CAPMC) epitomizes All of Us: (1) we have a large base from which to recruit
participants in a state that is committed to enhancing high quality research, and scientific excellence leading to
generalizability of findings; (2) the populations in our catchment areas are among the most diverse in the world;
and (3) we believe that All of Us’s intent to provide health data, risk assessment for particular conditions, and
tools for participants, citizen scientists, and researchers to make simple queries and obtain aggregate results in
a privacy-preserving manner is critical to the advancement of science.

Public health relevance
No Text